The Roles and Regulation of TLR7 in Systemic Lupus Erythematosus

Project Summary: Systemic lupus erythematosus (SLE) is a devastating autoimmune disease that causes
significant morbidity and mortality. Despite this, there has been only one new FDA-approved therapy for SLE
in the past 60 years, largely due to gaps in knowledge of disease mechanisms. In SLE, endosomal TLR7 and
TLR9 are known to mediate the anti-self response. Surprisingly, our lab found that TLR9 deletion in the
MRL.Faslpr model of SLE exacerbates disease, despite the requirement of TLR9 for formation of anti-chromatin
antibodies. This exacerbation is dependent on TLR7, suggesting that TLR9 is protective while TLR7 drives
pathology. A major goal of our lab is to understand these disparate roles of TLR7 and TLR9. We have found
that the downstream adaptor of TLR7 and TLR9 (MyD88) is required to mediate nephrotoxic T cell activation
in B cells and dermatitis development in dendritic cells. Thus, we hypothesize that TLR7 mediates
different aspects of SLE pathology in different immune cell subsets. We will define these cell-
specific roles by selectively deleting TLR7 in two MRL.Faslpr cohorts: one in B cells and the other in CD11c+
dendritic cells. We will comprehensively assess disease severity via kidney pathology, dermatitis, anti-self
response, lymphadenopathy, and analysis of immune cell repertoire after onset of autoimmunity. Given that
TLR7 exacerbates disease in the absence of TLR9, this will be repeated in TLR9-deficient mice to determine if
this changes how TLR7 contributes to disease.
Because of its pathogenic role, it also important to understand the regulation of TLR7. Our lab found that
NOX2-deficient mice have remarkably worse disease, including increased anti-RNA autoantibody titers. The
production of these autoantibodies is known to be TLR7-dependent. Recent work has shown that NOX2-
dependent reactive oxygen species (ROS) can modify a TLR7-specific cysteine residue to inhibit anti-viral
signaling. This cysteine, in the ectodomain of TLR7, has been shown to be required for RNA sensing and
signaling. Taking all of this data into account, we hypothesize that loss of NOX2 exacerbates
disease via dysregulation of TLR7. This will be studied using a twofold approach: First, we will cross
NOX2-deficient to TLR7 deficient-mice to determine if exacerbated disease driven by the absence of NOX2 is
dependent on TLR7. Second, we will use a mass spectrometry-based approach (OxMRM) in NOX2 deficient
cells to determine how NOX2 signaling affects TLR7 oxidation state in SLE. This research will occur in the
innovative, collaborative, and well-equipped environment of the M. Shlomchik laboratory at the University of
Pittsburgh. The training plan related to this key research includes comprehensive instruction in bench work,
data analysis, scientific communication and writing, and professional development. This will help me achieve
my long-term goal of becoming an independent scientist that contributes to our knowledge of autoimmunity.

Public health relevance
Project Narrative Systemic lupus erythematosus (SLE) is a devastating autoimmune disease, yet there are a lack of targeted therapeutics available due to incomplete understanding of underlying disease mechanisms. Investigating the biology of TLR7, a receptor shown to drive lupus pathology, is of great importance to provide rationale for future therapeutic design. As SLE shares features with other autoimmune diseases, this will also broaden our knowledge about autoimmunity overall.